Primate epigenetic and senescence biomarkers to advance aging science and anti-aging strategies.

PROJECT SUMMARY
A crisis for global healthcare systems is looming with an expanding aged population encumbered by numerous
age-related chronic diseases, driving interest and investment in therapies that improve healthspan. Strong
evidence now suggests that the aging process and age-related diseases are not separate entities and have
biological processes in common, including epigenetic changes and accumulation of senescent cells. A major
challenge in aging research is the development of biomarkers that can track the biological age of an individual
and discriminate, at an early stage, those on different health trajectories. As humans share much greater
biological similarity with nonhuman primates (NHPs) than rodents, this project is committed to the development
of epigenetic and senescent biomarkers based on NHP tissues, to allow aging biology and anti-aging studies to
be conducted before translation to human subjects. An important property of an aging biomarker is that is derived
from accessible tissues to allow minimally invasive sampling and longitudinal assessments; blood and skin are
ideal sources and are the focus of the present studies. Age-related changes in methylation of DNA at discrete
sets of dinucleotide CpG sites can be quantified and yield a biomarker tool (an epigenetic “clock”) that correlates
strongly with chronological age. Such clocks have been used to identify differences in biological aging that skew
individuals’ expected epigenetic age from that predicted by their chronological age. Accelerated epigenetic aging
is associated with many age-related diseases, and remarkably, predicts all-cause mortality risk, independent
from chronological age, lifestyle habits, and morbidity. Recent applications of epigenetic clocks in rodent studies
confirm that experimental manipulations that extend life slow the rate of epigenetic aging, a discovery indicating
that clocks satisfy the elusive criteria of a molecular biomarker of aging, though rodent aging differs significantly
from human demanding more translationally relevant studies. In addition, aging in many tissues is accompanied
by the accumulation of “senescent” cells that have exited the normal cell cycle, expressing a characteristic
pattern of proteins that provide convenient quantifiable markers that serve as an index of aging in proliferative
tissues. Skin comprises the largest organ in the body and detrimental skin changes, among the most visible
signs of aging, can mirror and model the impact of aging on internal organs. Intriguingly, senescent cells secrete
factors that induce senescence in other nearby or distant cells, likely contributing to organismal aging. This
proposal will harness the expertise and resources of the “Clock Foundation” (founded by Dr. Horvath and Robert
Brooke) and Virscio’s extensive nonhuman primate research resources to optimize and validate epigenetic and
senescent biomarkers in blood and skin. This research will lay the foundation for Virscio to commercialize the
ability to quantify induced changes in aging in a clinically relevant species, to test both therapeutic and adverse
effects, which is urgently needed to enable efficacy and safety testing of novel rejuvenating therapies emerging
from the growing number of industry and academic partners addressing critical healthspan extension strategies.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it establishes new tools to advance understanding of the aging process and enable evaluation of anti-aging interventions in a species relevant to human healthspan and lifespan. The research directly addresses the goals of NIA, with relevance to NIAMS, NIEHS, NCI, NHLBI, and NINDS and is relevant to the part of NIH’s mission that pertains to fostering fundamental discoveries and research strategies that will help to reduce the burdens of human disability and improve preclinical research outcomes and impact.